Embryonic type 3 innate lymphoid cells sense maternal dietary cholesterol to shape mucosal lymphoid organ development

Embryonic type 3 innate lymphoid cells sense maternal dietary cholesterol to shape mucosal lymphoid
organ development
Summary
During pregnancy, the fetal immune system develops in the uterine environment and relies on developmental
programs to initiate the organogenesis of secondary lymphoid organs, including spleen and lymph node. This
evolutionary conserved process endows the fetus with the ability to orchestrate the immune response after birth
and to react to the triggers present in the environment.
Lymphoid tissue inducer (LTi) cells are fetal innate lymphocytes that develop during intrauterine life and are
deputed to coordinate the development of secondary lymphoid organs. People with mutations in genes
controlling LTi have impaired lymph node formation and are predisposed towards mucocutaneus and systemic
infection. While it is established that LTi function is critical to prepare the neonate with a functional scaffold to
mount immune response, the mechanisms controlling anatomically distinct intestinal secondary organs
organogenesis are unclear.
We discovered that LTi that form intestinal the Peyer’s patches, gut-specific secondary lymphoid organs, require
the coordinated action of two migratory G protein coupled receptor (GPCR) GPR183 (EBI2) and the chemokine
receptor CCR6. However, the nature of the intestinal anatomical location attracting Peyer’s patches LTi and its
effect on LTi differentiation is unknown. In this project we will test the hypothesis that intestinal LTi cells position
themself in proximity of a differentiating “metabolic niche”: maternal diet provides the maturation cues, which is
a cholesterol byproduct generated in the neonatal gut by resident stromal cells.
This is a high risk and high reward project, designed to establish the critical importance of cholesterol metabolite
production and sensing for fetal innate lymphocytes differentiation in the gut. The conceptual basis is unique as
there are no precedents for the integration of GPCR- dependent maturation and metabolic switch in tissue
resident innate lymphocytes during development. Moreover, no metabolic regulation intimately linked to maternal
diet and mediated by fetal stromal cells that exploit same cues that will be generated during tissual adult function
have been reported.
This lack of precedent makes the project risky, but if proven to be accurate will fundamentally alter our
understanding of mucosal innate lymphocytes sensing of environmental alterations and expand the functional
domains of cholesterol and its byproducts in building and maintaining a healthy immune system, especially in
newborns.

Public health relevance
Narrative Fetal development is indissolubly associated with maternal health: maternal malnutrition heavily impacts the fetal immune system, especially in the context of immune responses to enteric pathogens and oral vaccines. We discovered that innate lymphoid cells that organize the development of Peyer’s patches, the main lymphoid organs of the gut, are regulated by maternal diet through the generation of specific metabolite required for immune cell maturation. This project will attempt to resolve the metabolic regulation of intestinal innate lymphoid cells and to prove the functional importance of cholesterol biosynthesis in mucosal tissue homeostasis of newborns.